Pathology and Biobanking

Abstract
The Pathology and Biobanking Core (PBC) has supported the efforts of the Baylor College of Medicine
Breast SPORE for 26 years, offering comprehensive pathology services to SPORE investigators and others. All
projects in this SPORE application propose the use of human biospecimens in assay development and for
retrospective and/or prospective clinical trials, and this shared resource core is structured to meet the demands
for high-quality, centralized banking and distribution of tissue specimens within this context. We have expertise
and dedicated personnel for all routine histological studies, immunohistochemistry, immunofluorescence, tissue
microarray preparation, and macro/micro-dissection techniques. Additionally, the Core supports advanced
microscopy and digital imaging capability. All projects will also benefit from our recent expansion of state-of-the
art molecular diagnostic platforms and high-complexity assay development, including quantitative PCR,
microfluidics-based digital droplet PCR (ddPCR), next generation sequencing (NGS).
The Core will provide the following services to projects and integration with other cores in this proposal:
1) a centralized resource to acquire, store, and utilize human biospecimens for cancer research; 2) To coordinate
and manage the pathology activities of the SPORE, and ensure that Project Investigators have ready access to
specialized pathology expertise and interpretation; and 3) to design and validate biomarker-based tests (genomic
and/or proteomic) that support all project stages, including clinically-validated and reported assays for SPOREbased clinical trials.
The SPORE benefits from integrated interactions between components, and this Core will work closely
with other cores, particularly the Informatics and Statistics Core (ISC) for project design and correlative analyses.
Further we will collaborate with the ISC to assist with selection and implementation of biospecimen repository,
tracking and management software that spans all SPORE components. We will work with the Administration
and Advocacy Core in management of laboratory resources and assist Career Development trainees with
education in assay development and experimental analysis. The Core will assist proposed and funded Pilot
Studies with exploratory assay design and technical validation support. The Pathology and Biobanking Core
Laboratory is seeking both CLIA- and CAP-certification to meet Precision Medicine initiatives of this SPORE at
Baylor College of Medicine.

Public health relevance
Narrative The Pathology and Biobanking Core seeks to improve the lives of breast cancer patients by facilitating novel translational biomarker discovery into the development and validation of clinical assays. This Core serves as a centralized repository for biospecimen acquisition and use, management of the histopathology activities of each SPORE project, and the development and validation of biomarker-based molecular testing that supports all stages of SPORE project development.